Genetics Predoctoral Training Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The Genetics Predoctoral Training Program (GPTP) at Emory University is a unique program in genetics, genomics and molecular biology that supports students to develop their technical, operational and professional skills so they can succeed in their desired career in the biomedical workforce. All students complete a rigorous curriculum in the associated graduate program in Genetics and Molecular Biology (GMB) emphasizing broad knowledge and its application in an ethical and reproducible manner. Additional coursework focuses on experimental design, statistics, rigor and the responsible conduct of research. Based on student interests, the curriculum provides enough flexibility to support students to develop advanced knowledge in their field. Students perform at least 3 rotations prior to selecting a dissertation mentor prior to their second year. A required grants course in the second year ensures students think deeply about their project from the onset. The resulting grant proposals form the basis of the oral qualifying exam which must be completed by the beginning of year 3. Students who submit the proposals have a high success rate in gaining individual funding through F31 and similar mechanisms. To enrich the training experience, the GPTP uses a validated, milestone assessment tool along with the individual development plan and an annual reflection meeting to create a student-centric, tailored and flexible training plan for each student. The custom training plans leverages the broad assortment of career development sessions afforded to students at Emory, and encourages an internship. These plans are augmented by informal mentoring with both peer and informal faculty mentors. The program is led by a Program Director and Steering Committee with deep expertise and commitment to graduate education. There are 48 training faculty, each of whom must complete training in mentoring in order to train a GPTP appointee. Students apply and matriculate in the affiliated GMB graduate program through a review process that evaluates each applicant’s research experience, personal statement, academics, letters of recommendation, trajectory, and potential for productivity. The program size provides the intellectual community to support interdisciplinary work and expose trainees to a breadth of cutting-edge genetics and genomics research. Five students per year will be appointed to the GPTP at the beginning of year 2, reappointed in year 3 and will remain affiliated with the program until graduation through annual reflection and planning, customized training activities and peer mentoring. The current time to degree is 6 years, which while on par with the national average, is likely to be reduced under the GPTP. The GPTP will institute a robust evaluation plan enabling optimization of program training activities. By ensuring a rigorous, student-centric training environment with clear expectations, the GPTP will empower students to be creative, independent thinkers as they enter the nation’s biomedical workforce.

Public health relevance
The Genetics Predoctoral Training Program (GPTP) at Emory University trains students in genetics, genomics and molecular biology. Through a rigorous yet flexible curriculum, dissertation research and customized career development training plans aligned to individual student competency-based assessments, students are prepared to obtain and succeed in the career of their choice within the biomedical workforce.